Mechanisms of transcriptional regulation to control inhibitory synaptic plasticity

PROJECT SUMMARY
GABAergic inhibitory synapses are critical for controlling neuronal excitability, fine-tuning neuronal output, and
coordinating neuronal firing. Inhibitory synapses undergo bi-directional, activity-dependent changes that result
in both changes to synaptic clustering and synaptic strength. In particular, one form of inhibitory long-term
potentiation (iLTP) results in increased post-synaptic clustering of the GABAA receptors (GABAARs) and the
inhibitory synaptic scaffolding protein, gephyrin. The clustering of both GABAARs and gephyrin at early stages
of iLTP is through trafficking of these proteins to synapses, but later stages of iLTP require de novo protein
synthesis in order to sustain this potentiation long-term. We have found that two microRNAs (miRNAs:
miR376c and miR153) repress the translation of GABAARs and gephyrin under basal conditions. Following
iLTP stimulation, miR376c and miR153 expression is reduced, resulting in increased GABAAR and gephyrin
translation required for sustained increases in inhibitory synaptic strength. This decrease in miRNA expression
is a result of transcriptional repression, mediated by the transcription factor, nuclear factor of activated T-cells
(NFAT), which is regulated upstream by the phosphatase calcineurin (CaN). However, there is still a major gap
in our knowledge of signaling mechanisms that control long-term changes in gene expression during inhibitory
synaptic plasticity. In this proposal, I will address this gap in knowledge by identifying the upstream signaling
cascades responsible for miR376c and miR153 transcriptional repression following iLTP, specifically
focusing on the role of both NFAT and the scaffolding protein, A-kinase anchoring protein (AKAP), which
mediates the anchoring of CaN in close proximity of calcium influx. I hypothesize NFAT transcription factors
regulated by AKAP-anchored CaN signaling are required for long-term strengthening of inhibitory
synapses during iLTP. I will utilize live-cell confocal microscopy and whole-cell electrophysiology to identify
the requirement for NFAT in increases in inhibitory synapse size, number and strength following iLTP
stimulation (Aim 1). Live-cell confocal microscopy, 3D-structured illumination microscopy (SIM), and slice
electrophysiology will be performed to characterize the role of AKAP-anchored CaN in regulating NFAT
translocation and inhibitory synaptic potentiation following iLTP stimulation (Aim 2). Together, this proposal will
help identify the upstream signaling mechanisms that are required to regulate altered gene expression during
long-term iLTP and will provide clarity on the mechanisms that regulate inhibitory synaptic plasticity, which are
vital for regulating proper circuit function and learning, memory, and cognition.

Public health relevance
PROJECT NARRATIVE GABAergic inhibitory synapses mediate inhibitory synaptic function in the brain, which is crucial for learning, memory, and cognition. Inhibitory synapses are critical for regulating neuronal excitability and mediating synaptic plasticity. Delineating the molecular mechanisms that control inhibitory synaptic plasticity is vital for our understanding of synaptic function and could provide critical insight into numerous neurological disorders.